ROLE OF SUPERANTIGENS IN TREATMENT OF RHEUMATOID ARTHRITIS

This study will measure the changes in antibody levels for staphlococcal proteins, superantigens, type II collagen, and tetanus in rheumatoid arthritis patients during treatment with the protien A column as well as analyze the ability of serum, pheresis affluent, and pheresis effluents from RA patients during treatment with the protein A column to produce and/or inhibit superantigen-induced mitogenic lymphyocyte proliferation.